Molecular Immunology Core

CORE SUMMARY / ABSTRACT
The MIC will provide a centralized hub for advanced cellular and systems immunological analysis of all biologic
samples derived from Projects 1-2. In addition, the MIC will coordinate and streamline all common assays and
procedures to ensure that both Projects utilize uniform Standard Operating Procedures (SOPs) and best practices.
The MIC is comprised of five interacting sub-Cores: (1) The MHC Immunogenetics and Typing Core; (2) the Flow
Cytometry and CyTOF Core; (3) The Virology and Functional Protective Immunity Core; (4) The Molecular Immunology
and Transcriptomics Core; and (5) The Computational Analysis Core. Each Core addresses an essential requirement
for the optimal conduct of the complex experiments that are proposed in Projects 1-2 and promotes collaboration
between investigators. As such, the MIC will significantly increase the efficiency and the rigor with which our group is
able to execute the lung transplant tolerance experiments proposed in this U19.